Comparative resistomics of Gram-negative bacterial pathogens

ABSTRACT
Increasing antibiotic resistance necessitates expanding research into the mechanisms by which bacterial
pathogens acquire and perpetuate drug resistance. Despite rapidly expanding genomic mapping of
resistance-conferring mutations in clinical isolates and laboratory studies, our knowledge of dynamics and
mechanisms underlying evolution of antimicrobial resistance is still insufficient. To fill-in this gap, the authors
of this proposal combine experimental evolution in a continuous culturing device, morbidostat, with time-
resolved ultradeep genomic sequencing of evolving bacterial cultures. The utility of the developed
morbidostat-based workflow is supported by published and ongoing studies with established antimicrobials
and experimental drug candidates. The preliminary results of comparative resistomics studies over a range
of Gram-negative bacterial species provided initial support to a premise that evolution of drug resistance in
morbidostat proceeds via a limited set of trajectories defined by a combination of resistance and fitness
constrains approximating clinical evolution, which favors selection of low-frequency/high-fitness over high-
frequency/low-fitness mutants. A comparative resistomics approach enables mapping of both universal and
strain-specific mechanisms as demonstrated in a recent proof-of-concept study on experimental evolution of
ciprofloxacin resistance in three Gram-negative bacteria. The proposed 5-year project will test the central
hypothesis and extend exploration of antimicrobial resistome by pursuing the following specific aims: (i) in
Aim 1, the established morbidostat-based workflow will be used to determine major mechanisms driving
resistance to broad-spectrum clinical antibiotics, ciprofloxacin, colistin, tigecycline and meropenem, in four
difficult-to-treat Gram-negative bacterial pathogens, Acinetobacter baumannii ATCC17978, P. aeruginosa
ATCC27853, E. coli ATCC25922, and K. pneumoniae ATCC13883; (ii) in Aim 2, a representative panel of
selected clones will be systematically characterized to assess the effects of individual mutations and
combinations thereof on acquired resistance and fitness; (iii) Aim 3 will leverage a moribidostat-based
workflow to make first steps toward experimental evolution of multidrug resistance focusing on A. baumannii
and starting from clones selected in single-drug evolution studies. The results that will be obtained in all
planned studies will be a subject of in-depth bioinformatics analysis (including comparison with public data
for clinical isolates), predictive modeling, integration and sharing with broad research community via a
specialized web-site on integrative Genomics of Evolution of Antimicrobial Resistance (iGEAR). The proposed
study is expected to have translational impacts in advancing methodology to support rational optimization of
antibiotic treatment regimens and development of new drugs with minimized resistibility.

Public health relevance
NARRATIVE This study will combine experimental evolution with comparative genomics to establish universal and unique mechanisms driving acquisition of resistance in four difficult-to-treat Gram-negative bacterial pathogens to four major clinical antibiotics. The developed methodology and obtained results will support rational optimization of therapeutic regimens and development of new drugs with minimized resistibility.